Regulation and Neural Function of Atypical PKC

Long-term memories are believed to be due to persistent changes in synaptic strength. Although the molecular mechanisms initiating these changes have been extensively studied, the mechanisms maintaining these changes, which may contribute to storing long-term memory, have been unknown. Recently, however, a candidate molecular mechanism has emerged for maintaining a persistent form of synaptic enhancement triggered by strong afferent stimulation of synapses, known as long-term potentiation (LTP). The key molecule in this maintenance mechanism is a brain-specific, protein kinase C isoform, PKMζ. Unlike other PKC isoforms that require second messengers for activation, PKMζ consists of an independent PKC catalytic domain that is constitutively active. PKMζ is produced from a PKMζ mRNA, and the amount of the kinase increases with LTP induction. The persistent activity of the kinase is then both necessary and sufficient for maintaining the synaptic enhancement. Postsynaptic perfusion of PKMζ enhances synaptic transmission, and inhibition of PKMζ activity reverses previously established LTP. Recently, PKMζ inhibition has been found to disrupt the storage of previously established long-term memories. These data indicate that PKMζ is a candidate molecule uniquely important for information storage at synapses and during behavior. Thus the overall goal of this application is to elucidate in mechanistic detail the function of PKMζ in persistent synaptic enhancement and memory storage. Our 3 Specific Aims are: 1) To characterize the mechanisms by which PKMζ enhances synaptic strength. We found that PKMζ potentiates synaptic strength by increasing the number of postsynaptic AMPA receptors (AMPARs) through interactions between the AMPAR GluR2 subunit and the trafficking protein NSF. We will examine whether this potentiation is through increased exocytosis and/or decreased endocytosis of postsynaptic AMPARs and the function of this altered trafficking in memory maintained by PKMζ. 2) To determine whether preexisting and newly translated PKMζ mediate distinct phases of potentiation during LTP. Preliminary evidence indicates that antisense oligodeoxynucleotides blocking new PKMζ synthesis prevents the persistence of a phase of LTP. We will determine whether this new synthesis occurs at dendritic sites. 3) To determine the role of preexisting, newly translated, and new gene transcription of PKMζ in distinct phase of memory. PKMζ maintains memory up to several months after training. We will employ both antisense to block translation of PKMζ mRNA and conditional genetic deletion of PKMζ to examine the function of distinct mechanisms of expression of PKMζ in different phases of memory. These 3 aims will provide fundamental new information on a potential molecular mechanism for maintaining synaptic and behavioral information storage, which may be relevant to both normal memory and its disorders.

Public health relevance
How long-term memories are stored in the brain is a fundamental neurobiological question, with many implications for neurology and psychiatry, but the molecular mechanisms of memory maintenance have been unknown. Recently, however, the persistent action of a protein kinase, termed PKMζ, has been found to be one potential mechanism for maintaining memory. This application is to characterize the functional mechanisms by which PKMζ maintains long-term information at synapses and during behavioral memory storage.